3D-Printed Glass Micro-Optical System for Biomedical and Clinical Applications

Abstract
Micro-optics play a crucial role in biomedical imaging, particularly in endoscopic systems, providing unparalleled
advantages in compactness and resolution. However, as the dimensions of micro-optical systems shrink to
address clinical demands, the limitations of traditional systems become more apparent, often resulting in
potential compromises in optical performance.
Recognizing the growing demand in medical arenas and current optical fabrication constraints, we introduce a
novel glass micro-optical system where all components are fabricated together as a single unit, with the optical
portions transparent and the non-optical portions black. This eliminates the need for mechanical components for
structural integrity or to block stray light. This innovation is transformative rather than incremental, enabled
solely by the proposed 3D printing techniques and materials. Leveraging the support from the
R21CA268190 grant in recent years, we've demonstrated the merits and potential of 3D-printed glass micro-
optical systems. By pioneering new printing materials and novel two-photon polymerization (TPP) printing
processes, we've developed glass micro-optical systems possessing attributes unattainable through any other
manufacturing methods and commercial system, such as GRIN lens. Central to our proposed glass micro-optical
system is its holistic integration, which circumvents traditional assembly and alignment hurdles. We've also
pioneered materials with a higher refractive index, innovative printing techniques for localized transparency
control, and multi-material printing to enhance imaging performance.
Our goal is to develop and promote glass micro-optical systems tailored for biomedical and clinical imaging. We
will first build a custom 3D printing system with a large field of view (FOV) to achieve high throughput and enable
the printing of large glass micro-optical systems, thereby overcoming the limitations of commercially available
TPP printers. Concurrently, we will investigate new printing materials with higher refractive indices to enhance
imaging quality. We'll also fine-tune printing techniques that control local transparency to boost image contrast
and optimize multi-material printing process to improve system performance across a wide spectrum. Ultimately,
we aim to design and fabricate three types of glass micro-optical systems, evaluate and compare their
performances with commercial GRIN lenses and microscope objective in white light, autofluorescence, and
confocal imaging modes with tissue samples.
The anticipated impact of this project is substantial, heralding the advent of compact glass micro-optical systems
that were previously inconceivable, featuring unparalleled imaging capabilities. Such advancements could
expedite the transition of revolutionary imaging tools from the lab to tangible clinical settings. This endeavor
promises not only innovations in imaging capabilities but also cost-effective rapid prototyping solutions, unlocking
previously unattainable applications in biomedical and clinical imaging.

Public health relevance
Project Narrative Our project focuses on developing a novel 3D-printed glass micro-optical system for biomedical and clinical imaging applications, addressing the limitations of current glass micro-optical systems. We aim to create cutting- edge 3D printing technology and materials to fabricate micro-optical systems that offer unparalleled compactness and imaging performance. The unique properties of our proposed 3D-printed glass micro-optical systems are pivotal, with the potential to drive transformative advancements in biomedical and clinical imaging.